CORE--FIELD OPERATIONS

The aims of the Field Operations Core are: 1) to provide centralized subject recruitment, enrollment, assessment and surveillance services to the two planned intervention studies and pilot studies of the OAIC, 2) to provide technical assistance to junior faculty in the development of research protocols and their implementation in the field, 3) to collaborate with the Design, Analysis and Data Management Core to insure uniformity of methods and measurement when appropriate among OAIC studies, and 4) to train Core staff in uniform and reliable interview and assessment methods. The allocation of resources to this Core will produce economies of scale and reduce duplication of effort among OAIC studies. Standard Operating Procedures will be established that can be modified to meet specific study needs while retaining a common core of measures and field methods.